Generation of Chimeric DNA-RNA Structures using Engineered Replisomes in vivo

PROJECT SUMMARY/ABSTRACT
The evidence of ribose in ancient catalytic machinery such as the ribosome as well as a universal set of cofactors
which are derived from ribonucleic acids (RNA) has led to the hypothesis that RNA was once the dominant
biopolymer in life. The transition from an RNA to DNA world raises a multitude of questions regarding how life
was able to support such a dramatic change in the most fundamental information storage molecules without
compromising survival. Recent studies have shown that certain randomly mutagenized strains of E. coli are in
fact capable of supporting surprisingly high amounts of RNA in their genome, however it remains unclear the
exact biochemical mechanisms that allow this to occur, and further studies of these strains is challenging due to
inherent instability of their genomes. In this project I will be developing a novel polymerase system which could
potentially limit RNA incorporation to small regions of DNA such as a plasmid. Targeting RNA incorporation in
this way will allow for the first time a systematic method to study the effects of high ribose content in genes,
without compromising host genomes.
The proposal outlined here will focus on strategies for engineering the DNA polymerase within the multienzyme
viral genome replication machinery known as the T7 replisome. In Specific Aim I, I will outline a plan to study the
effects of focused mutations within the active site of T7 DNA polymerase. This will include the development and
implementation of 96-well based screening method for the rapid determination of DNA polymerases with the
ability to incorporate RNA permissively. Specific Aim II details a protocol for the selection of RNA permissive
DNA polymerases from much larger mutant pools. A key feature of this aim is the combination of phage-display
which has been used for the selection of nucleotide promiscuity in vitro along with a complementation-based
selection strategy which further selects for mutant polymerases that retain functionality in vivo. We hypothesize
that a novel combination of these strategies can be used to solve the inherent limitation of phage display to in
vitro reaction conditions which may not accurately reflect intracellular conditions. Finally, Specific Aim III details
a new approach toward the selection of mutant polymerases with the ability to incorporate RNA into replicating
plasmids within a bacterial host. This method will rely on the use of alkyne labeled ribonucleotides which will
provide chemical handles for the enrichment of plasmids that encode polymerases with relaxed sugar specificity.
Together this project will create progress toward an orthogonal polymerase system for the construction of
chimeric DNA-RNA plasmids in vivo, a task which is currently impossible using known synthetic biology tools.

Public health relevance
PROJECT NARRATIVE The storage and retrieval of genetic information in the form of DNA is a fundamental aspect of biology and is crucial to our modern understanding of life. This project proposes to use a combination of protein engineering strategies to enable T7 DNA polymerases involved in viral genome replication to synthesize mixed DNA-RNA plasmids within a bacterial host. The development of these orthogonal polymerases will provide an important tool for understanding fundamental aspects of biological information storage and would represent a significant advance in methods to access these unique biopolymers in vivo.